Deep South Center HIV Pilot Extension Program

PROJECT SUMMARY – HIV Pilot Extension Program
The mission of the Deep South Center to Reduce Disparities in Chronic Diseases is to promote health equity
and reduce the burden of cardiometabolic diseases across the Deep South. The Center represents a
partnership between the University of Alabama at Birmingham, Tuskegee University, Pennington Biomedical
Research Center, and the University of Mississippi Medical Center, along with regional non-academic partners
to translate and sustain cardiometabolic research in real-world community and clinical settings. In addition to
three R01-level projects implementing multi-level interventions to address cardiometabolic disease, the Center
includes three Cores, the Administrative Core, the Community Engagement Core (CEC), and the Investigator
Development Core (IDC). The Center is unified thematically through the application of a precision public health
approach across the care continuum to achieve health equity and brings together a trans-disciplinary team of
investigators from multiple academic institutions across the region along with non-academic partners with the
expertise and experience necessary to achieve this long-term mission.
With the HIV Pilot Extension Program, we will extend our Center’s focus on research in cardiometabolic
disease to include health equity in HIV. Specifically, we propose the following three additions to the current
IDC and CEC initiatives. First, we will fund an additional 3 pilots/year focused specifically on health equity in
HIV, with the maximum budget for any one project supported by the IDC being $50,000. Second, we will add
expertise in HIV health equity research to the Center’s Core Faculty. Drs. Latesha Elopre and Aadia Rana
bring extensive experience in HIV outcomes and health equity research. As part of the Investigator
Development Core, they will oversee the HIV Pilot Extension Program. They will also provide methodological
and content expertise through the Translational Design subunit of the IDC. Third, by leveraging existing
partnerships within the UAB Center for Aids Research and through Drs. Elopre and Rana’s programs of
research, we will add non-academic partners to our existing community coalition. By adding a focus on HIV
health equity research, particularly as it applies to the intersection between HIV and cardiometabolic
conditions, this revision will increase the breadth of content and methodologic expertise and amplify the overall
impact of the Deep South Center to Reduce Disparities in Chronic Diseases on health equity in the region.
.

Public health relevance
PROJECT NARRATIVE – HIV Pilot Extension Program The mission of the Deep South Center to Reduce Disparities in Chronic Diseases is to promote health equity and reduce the burden of cardiometabolic diseases across the “Deep South” region of the United States that includes Alabama, Mississippi, and Louisiana. A key component of fulfilling this mission is growing and diversifying the workforce with the expertise necessary to conduct research related to dissemination and implementation, comparative effectiveness, and translation of evidence-based interventions for real-world settings. The Investigator Development Core’s HIV Pilot Extension Program will extend our Center’s focus on research in cardiometabolic disease to include health equity in HIV. By adding a focus on HIV health equity research, particularly as it applies to the intersection between HIV and cardiometabolic conditions, this program will increase the breadth of content and methodologic expertise and amplify the overall impact of the Deep South Center to Reduce Disparities in Chronic Diseases on health equity in the region.